Center for Pediatric Research

OVERALL
PROJECT SUMMARY
The primary goal of this application is to continue to harness the capabilities of the Center for Pediatric Research
to support basic and translational scientists studying mechanisms underlying children’s disease and associated
treatment options. The origin of many pediatric diseases is from altered developmental programming related to
the processes of cell proliferation, morphogenesis, migration, differentiation, and programmed death. These
developmental processes are at the root of pediatric disease and are disrupted through genetic disorders,
aberrant fetal programming, altered growth & development, and environmental pressures. Our multidisciplinary
Center applies genetic, biochemical, cell, and molecular approaches across several model organisms to
characterize alterations during development as they pertain to pediatric diseases and disorders. For Phase III
we will continue to build upon the success of Phase I and II efforts in creating a critical mass of independently
funded investigators within the Center for Pediatric Research by refining our focus to support and mentor both
new and established investigators. Center success will be achieved through the following Aims: 1) maintain a
supportive environment for the training and mentorship of scientists studying pediatric disease to strengthen and
grow the Center membership; 2) utilize and enhance existing Core resources that support pediatric research
with a focus on long-term sustainability; 3) expand training and learning opportunities relevant to pediatric
disease; and 4) evaluate success of the Center. Through these Aims, the Center for Pediatric Research will
develop a strong foundation in basic and translational research by fostering a collaborative environment for
scientists and physicians. Strengthened by our institution’s strong commitment to children’s medicine, Phase III
funding will be instrumental in enhancing pediatric research efforts in the Center, the region, and beyond.

Public health relevance
OVERALL PROJECT NARRATIVE We will continue to develop a multidisciplinary research center focused on understanding and treating childhood diseases. The Center will sustain its supportive environment for scientists investigating the basis of and approaches to treat pediatric disease, specifically through high quality research Cores and sustained training and mentorship. Additionally, through careful and continual evaluation the Center will ensure its Cores and investigators are set up for success and self-sustainability post COBRE.